Epigenetic regulation of erythropoiesis

Project Summary/Abstract
Histone deacetylases (HDACs) are a group of epigenetic enzymes that are important in regulating gene
transcription and other cellular processes. HDAC1 is implicated in various developmental program, including
hematopoiesis. We and others have showed the GATA-1 can interact with HDAC1 containing NuRD
corepressor complex in FOG-1 dependent manner for GATA-1 mediated gene activation and repression. We
have also established that GATA-1 can interact with HDAC1 through a FOG-1 independent manner. This
interaction is essential for GATA-1 deacetylation and erythrocyte differentiation in vitro, and erythrocyte and
megakaryocyte differentiation in mice. The repression function through this interaction can be two folds, it may
through constitutive acetylation of GATA-1 and it may also through loss of HDAC1 interacting proteins. We
have performed proteomic analysis and found that GATA-1 interacts with BCL11A through HDAC1 dependent
manner. Therefore, we hypothesize that HDAC1 regulates GATA-1 activity through deacetylation and
interacting with key regulators that mediates erythroid differentiation and globin gene expression. In
this proposal, we will first investigate the role of GATA-1 acetylation in GATA-1 mediated gene transcription
program and global GATA-1 recruitment and chromatin accessibility. We have identified key interacting
proteins with acetyl-mimicking and non-acetyl-mimicking proteins through LC-MS/MS. We will perform in-depth
studies on differential recruitment of other GATA-1 interacting proteins that potentially alter GATA-1 binding
landscape and target gene expression in vitro and in a mouse model. We will also study the importance of
HDAC1 mediated GATA-1 and BCL11A interaction in fetal globin gene expression and erythroid differentiation.
Preliminary Cut and run study showed that the BCL11A KD or mutation reduces GATA-1 recruitment at fetal
globin locus but not at adult globin locus, suggesting negative role of GATA-1 in fetal globin gene expression.
This claim is further supported by significantly upregulation of fetal globin gene expression in Mx1 cre GATA-
1cKO mice. We therefore will study the mechanism of how GATA-1 negatively regulates fetal globin gene
expression. We will study how BCL11A regulates GATA-1 recruitment and activity in fetal globin gene
expression and how GATA-1 collaborate with BCL11A for -globin gene repression. The role of GATA-
1/BCL11A interaction in globin gene promoter/enhancer interaction and global genome organization will also
be study to have a comprehensive view of the role of GATA-1 in regulating erythrocyte function through
interacting with BCL11A. Thus, this study will lead to novel in depth understanding of GATA-1 function in
erythropoiesis and beyond.

Public health relevance
Project narrative: This grant application proposes to study how histone deacetylase 1 (HDAC1), an important epigenetic regulator for eukaryotic gene transcription, controls erythropoiesis through regulating a key transcription factor, GATA-1.